Methamphetamine and Cysteinyl Leukotrienes in HIV Persistence

Use of psychostimulant drugs, such as methamphetamine (METH), is a frequent comorbidity in people living with
human immunodeficiency virus (HIV)-1 (PWH). The interaction of virus and addictive substance, in particular with
regard to viral persistence, is poorly understood and will be studied here using in vitro and in vivo approaches in
combination with single cell (sc) and single nuclei (sn) RNA-sequencing. We observed that METH in combination
with a single-stranded (ss) RNA mimic of the HIV long terminal repeat (LTR) that acts as TLR7/8 ligand
upregulates components of the arachidonic acid (AA) pathway, including cysteinyl leukotriene synthase (LTC4S),
which produces cysteinyl leukotrienes (CysLTs). We also found that i) CysLT receptor 1 (CYSLTR1) expression
in HIV+ brain correlates with HIV DNA and RNA, ii) CYSLTR1 is upregulated in cerebral cortex of cART-receiving
PWH with brain pathology, iii) CysLTs released by HIV-1 infected macrophages (MΦ) and CYSLTR1 play a
critical role in neurotoxicity, and iv) Pharmacological blockade of CYSLTR1 abrogates neurotoxicity of HIV-
infected MΦ. Therefore, we propose here to investigate, if the CysLT-CYSLTR1 axis plays a causal role in the
promotion of HIV-1 persistence and brain injury by METH in the presence of cART. Three Specific Aims are
proposed: 1) To determine how methamphetamine engages the CysLT-CYSLTR1 axis and increases HIV-1
infection of peripheral blood CD4+T-cells and macrophages in the presence of cART. This aim will test the
hypothesis that METH engages the CysLT-CYSLTR1 axis to escalate HIV-induced inflammation, viral production
and reservoirs despite cART through upregulation of proviral host factors, incl. lncRNAs. 2) To investigate
whether inhibition of CYSLTR1 combined with cART ameliorates brain damage by METH and HIV in humanized
CD34+ HSC-engrafted NSG-SGM3 mice. This aim will test the premise that METH upregulates the CysLT-
CYSLTR1 axis to drive HIV-induced inflammation, infiltration of infected MΦ and CD4+T-cells into the brain and
neuronal damage despite cART. This aim will also assess if the clinically approved, CNS-penetrating CYSLTR1
inhibitor Montelukast (MTLK) abrogates those pathological processes. 3) To assess in vitro how the blockade of
CYSLTR1 enables neuronal survival in the presence of METH, cART and HIV-induced macrophage toxins. This
aim will investigate the hypothesis that blockade of CYSLTR1 enables neurons to suppress cellular signaling
pathways promoting inflammation, cellular stress, injury and apoptosis, such as those mediated by p38 MAPK
and JNK, in favor of pro-survival and cytoprotective pathways, such as activation of PKB/Akt and ERK1/2. The
experiments will be performed in vitro with isolated human peripheral blood cells and iPSC-derived neurons and
in vivo in humanized mouse model that provides HIV permissive human peripheral CD4+T-cells and MΦ. All
three Specific Aims will define RNA signatures of HIV-1 infected CD4+ T-cells and MΦ in the presence and
absence of METH, cART, and MTLK using sc and sn RNA-sequencing, and will test the proposed mechanisms,
including the interference of METH with TLR7/8 function, leading to increased inflammatory CysLT production.

Public health relevance
HIV infection and methamphetamine use disorder (MUD) remain substantial public health concerns and despite the availability of antiretrovirals (ARVs) and combined ARV therapy (cART). Methamphetamine use disorder is known to increase the risk of contracting HIV-1, increases viral titers despite cART and is associated with inflammation, neurocognitive impairment and brain injury. The purpose of the proposed research is to better understand the cellular and molecular mechanism, specifically the role of pro-inflammatory cysteinyl leukotrienes, underlying the compromising effect of the psychostimulant on cART-dependent viral suppression in order to better counter viral persistence, recrudescence and the associated chronic inflammation and brain injury.